Synaptic plasticity in sensory learning

ABSTRACT
Experience-dependent plasticity is a canonical feature of the neocortex, observed in both sensory and
motor learning as well as more sophisticated cognitive operations such as working memory. The
remarkable conservation of cell types and synaptic connectivity across brain areas suggests that there
may be general principles by which neocortical circuits facilitate experience-dependent synaptic
modifications relevant for learning. We will test the hypothesis that exposure to novel and rewarded
sensory inputs initiates a common program of cell-type and input-specific plasticity across the cortical
column, irrespective of whether these changes are required for behavioral change. These collaborative
studies will address and resolve important controversies in the field of learning.

Public health relevance
NARRATIVE Sensory learning changes synapses in the neocortex, but recent studies suggest that these synaptic changes are not required for behavioral changes in some cases. Here we will attempt to understand how input-specific synaptic plasticity is engaged during different types of sensory learning in mice. These studies will help us understand how learning drives a program of synaptic change that reshapes cortical responses, critical for understanding brain plasticity during normal behavior as well as after injury.